PATIENTS W/ REFRACTORY PARTIAL SEIZURES

Pregabalin open-label, follow -on safety trial in patients w/refratory partial epilepsy. objective of study is to evaluate the saftey of pregabalin at dosagess up to 600 mg/day in patients w/intracable complex partial seizures w/or without secondary generalization who had participated in the core trial w/pregabalin as part of an evaluation to determine their suitability for surgical treatment of complex partial seuzures & wish to receive follow-on, opne-label pregabalin therapy. 4-12 patients will be recruited for the study at this site.